Imaging Cells and Tissues with Super-Resolution Structured Illumination Microscopy

Imaging Cells and Tissues with Super-Resolution Structured Illumination Microscopy - Project Summary
Fluorescence optical microscopy is one of the most important tools available for the study of biological systems
at the cellular level. Unfortunately, due to diffraction phenomena the resolution of fluorescence microscopes in
the lateral dimension is limited to about 250 nm. As many biological structures within cells are much smaller than
this, increasing resolution is of prime importance. Although several methods are now available which are able to
extend the resolution of optical microscopes beyond the diffraction limit, imaging cells and tissues with these
methods remains a challenge.
Super-resolution structured illumination microscopy (SIM), which can achieve a resolution of approximately 100
nm, is a suitable super-resolution method for cells and tissues. However, adoption of this technique by biologists
is hindered by the inflexible equipment and artifact-prone image analysis algorithms which are currently
available. The solution to this problem demands innovations in both optical design and in data processing
methods which are used in SIM. In particular, imaging deeper into tissues with SIM has not been realized so far.
The goal of this interdisciplinary project is to develop, improve, and utilize super-resolution microscopy with a
focus on imaging both cells and tissues. In Aim 1 we will develop alternative illumination approaches for SIM
using economical components, and we will develop and implement improved SIM reconstruction algorithms
which produce results with higher resolution, quality, and more reliable results than are available with current
methods. These methods will allow imaging into tissues up to 500 micrometers, about 10-fold better than current
technology allows. In Aim 2, we will develop new algorithms based on machine learning for optical sectioning
microscopy and for denoising of microscopy images. In Aim 3, we will use the newly developed suite of methods
for studies of the molecular basis of allergic responses. We will use structured illumination microscopy to study
the relationship between cell surface receptors and the morphology of the plasma membrane, and we will
develop a reaction-diffusion model to better understand the biophysics of the cell membrane.

Public health relevance
NIH-R15: Imaging Cells and Tissues with Super-Resolution Structured Illumination Microscopy Project Narrative Several methods are now available which are able to produce optical fluorescence microscopy images of cells and tissues with a resolution that is not limited by diffraction. These methods, known together as super-resolution microscopy, are currently limited in their capabilities and applications when imaging tissues and live cells. This interdisciplinary AREA project will improve super-resolution microscopy for studies of the molecular basis of allergic responses, which affect more than 50 million Americans each year.